Clinical Shared Resource

Project Summary Core 3
The Clinical Research Support Core 3 is dedicated to two major efforts: biobanking and translating preclinical
data into studies. First, we are responsible for consenting and collecting biospecimens from patients with
MDS/AML at times of diagnostic procedures and at scheduled timepoints in clinical trials for ancillary studies.
We will obtain samples at diagnosis, remission, and relapse and transfer them to Biospecimen Core 1 for clinical
annotation and availability for scientists in the projects. Project 1 focuses on identifying the potential therapeutic
role for another anti-apoptotic protein BFL-1 (also known as A1), which has been understudied in AML. This
Letai-led project requires human leukemic blasts for routine and dynamic BH3 profiling to reveal functional and
pharmacologic dependencies based on mitochondrial apoptotic response. Ebert-led Project 2 focuses on the
biology of MYB degradation in response to microtubule destabilization and its implications on MYB-dependent
leukemia. Recently, menin inhibitors have demonstrated clinically meaningful activity among distinct AML
subsets with preclinical groundwork laid by the Armstrong lab. The immediate next step to advance the field is
to prevent single-agent resistance. The Armstrong and Fischer labs (Project 3) will examine the role of menin in
maintaining KMT2A complex stability and chromatin conformation, and preclinically evaluate new menin
degraders. Project 4 focuses on R-loop regulation and the therapeutic implications of targeting cGAS and STING
pathways to resolve R loops in cohesin-mutated MDS/AML. Second, Core 3 will design and execute clinical
trials emanating from the science described in the projects. We anticipate at least one clinical trial during the
funding period, including a menin and KAT6A inhibitor study in AML. After the funding period we anticipate
additional development of a proof-of-concept study in cohesin-mutated MDS/AML once a therapeutic
cGAS/STING modulator is identified. The overarching goal of the clinical trials is to improve the outcome of
patients with leukemia. Clinical trial designs including dose scheduling, pharmacodynamic analysis, and
correlative studies to confirm target engagement, will be informed by Biostatistical Core 2. Biostatistical Core 2
will also assist in the analysis of clinical and correlative data for publication. Rigorous biobanking with clinical
annotation will provide opportunity for sample use in assays within the projects, which will inform leukemia
biology, and potentially reveal additional targets that can be exploited. Collaboration directly facilitated by this
grant will accelerate translation of these findings into scientifically driven clinical studies.

Public health relevance
Project Narrative The Clinical Research Support Core 3 will support collection and delivery of clinical samples to biospecimen Core 1, under the guidance of Biostatistical Core 2 for performance of relevant assays with all four projects. Core 3 will be responsible for the design and conduct of clinical trials based on science emanating from Project 3.